Single-cell (phospho-)proteomics platform for functional analysis of tumor microenvironment

ABSTRACT
Tumor microenvironment (TME) is a complex ecosystem comprised of cancer cells, immune cells, stromal
cells, and other cell types. They interact and collectively determine disease progression and response to
therapy. To achieve a complete picture of TME, multi-omics single-cell technologies are needed to
characterize diverse individual cells within TME at both genotype and phenotype levels. Such analysis holds
promise to move towards precision medicine. However, single-cell proteomics technologies are lagging far
behind other single-cell omics technologies. Many studies have shown that mRNA abundance is a poor
surrogate for protein abundance and cannot provide any insights into protein activity regulated by protein
phosphorylation. Therefore, single-cell (phospho-)proteomics is critically important to provide complementary
data that cannot be achieved by other omics technologies. Antibody-based immunoassays are primarily used
for functional analysis of single cells, but they only can open a small window into the complex TME ecosystem
due to their inherent limitations. Mass spectrometry (MS)-based (phospho-)proteomics is a powerful tool for
genome-scale proteome profiling and site-specific quantification of 1,000s of phosphorylation sites. However, it
does not meet the merit for single-cell (phospho-)proteomics analysis. There are three major challenges that
need to be addressed: 1) low recovery for phospho-enrichment, 2) insufficient MS sensitivity, 3) low sample
throughput. We propose to develop a single-cell (phospho-)proteomics platform to address these three
challenges for robust rapid analysis of single cells at both proteome and phosphoproteome levels. The project
feasibility is strongly supported by our recent progress in many aspects of technology development. The new
platform will be developed through integration of a high-recovery sample preparation platform for single-cell
processing and phospho-enrichment with a high-efficiency MS platform to enhance MS detection sensitivity
and sample multiplexing to improve sample throughput. We envision that the single-cell MS platform will
eventually become an indispensable tool for robust, rapid, deep (phospho-)proteomic analysis of single cells
and TME. In turn, it will make substantial contributions to improve our understanding of cancer biology and
accelerate the movement towards precision medicine.

Public health relevance
NARRATIVE Tumor microenvironment (TME) is a central component of the tumor landscape. However, there is an unmet technical challenge for high-resolution, spatial, comprehensive, proteomic characterization of TME. We aim to develop a transformative single-cell proteomics technology for rapid comprehensive characterization of TME to meet current biomedical needs. This technology will lead to gain insights into tumor cell neighborhoods, cell to cell interactions, tumor heterogeneity, and spatial tumor biology for better treatment and patient care.